Roles of LMP1 and MYC in EBV-induced B-cell tumors

PROJECT SUMMARY/ABSTRACT
Epstein-Barr virus (EBV) is an important cause of human lymphomas in both immunocompetent and
immunosuppressed humans, including Burkitt lymphomas (BLs), Hodgkin lymphomas (HLs) and diffuse large B
cell lymphomas (DLBCLs). There are three different types of EBV latency (types I, II and III) that differ in the
number of latent viral proteins expressed and transforming ability. Only type III viral latency (in which all 9 latent
viral proteins are expressed) can transform primary human B cell in vitro, but because type III latency is highly
immunogenic, EBV+ tumors with type III latency in humans are relatively rare and largely found in
immunosuppressed hosts. EBV+ HLs and DLBCLs in humans commonly have type II latency (characterized by
expression of EBNA1, LMP1 and LMP2A), while EBV+ BLs, which contain MYC translocations, have type I
latency (in which EBNA1 is the only viral protein expressed). However, there is currently no in vivo or in vitro
model available to study how EBV infection causes lymphomas with type I or type II latency, since this form of
viral latency is not transforming in vitro and wild-type EBV-induced lymphomas in humanized mouse models
inevitably support type III latency. EBNA2 transcriptionally activates each of the latent viral promoters used
during type III latency. Using a newly constructed EBNA2-deleted EBV mutant (ΔEBNA2 EBV) made by our lab,
we have developed a novel culture system that allows us to stably infect primary naïve B cells in vitro with this
mutant, and to examine the effect of MYC over-expression. Our exciting preliminary results show that B cells
infected with ΔEBNA2 EBV form DLBCL-like and HL-like tumors with type II viral latency at late time points in
NSG mice, and that over-expressing the MYC gene (using a retroviral vector) in ΔEBNA2 EBV-infected B cells
results in rapid onset of aggressive tumors that resemble human BLs and support type I EBV latency. In contrast,
expression of MYC alone does not cause tumors in this model. As human BLs, DLBCLs and HLs are derived
from germinal center (GC) B cells, in Aim 1, we will use this new model to examine the ability of ΔEBNA2 EBV-
infected primary GC B cells (with or without MYC over-expression) to form lymphomas in NSG mice. In Aim 2,
we will identify the specific EBV genes (and/or viral RNAs) required for the development of ΔEBNA2 EBV-
induced tumors (with or without MYC) in naïve versus GC B cells. In Aim 3, we will define mechanisms by which
MYC turns off LMP1 expression in ΔEBNA2 EBV-induced lymphomas and determine if small molecules that can
restore LMP1 expression enhance the immune response to tumors in humanized mice. The proposed
experiments will provide the first model system to define how types I and II EBV latency cause lymphomas in
human GC B cells and to ask if restoration of LMP1 expression in BLs enhances the host immune response.

Public health relevance
PUBLIC HEALTH RELEVANCE Epstein-Barr virus (EBV) is an important cause of human lymphomas such as Burkitt lymphomas (BLs) and diffuse large B cell lymphomas (DLBCLs) that have stringent forms of viral latency (types I and II) that cannot transform B cells in vitro. We have recently developed a new model system that allows us to obtain EBV-infected BL-like lymphomas with type I latency and EBV-infected DLBCLs with type II latency in naïve B cells. In this proposal, we will extend this model into primary human GC B cells, define the specific EBV genes and/or RNAs required to form each tumor type, and identify pathways that restore expression of the EBV LMP1 protein in BL- like tumors, thereby enhancing the T cell response to BL-like tumors in humanized mice.